Environmental Lung Disease Research Core

The goals of the ELDRC are to enhance epidemiologic, etiologic, and clinical research related to the detection, ascertainment, intervention, surveillance, and etiology of environmental and agricultural airway diseases and to link ELDRC scholars to other EHSRC investigators in synergistic collaborations. The translation of environmental lung disease research of EHSRC investigators is highlighted above in §2.2.4. Ongoing research by core researchers is aimed at better understanding the causal relationship between environmental exposures and lung diseases including the relative risk of exposures and the modifying risk factors related to exposure.